Quantitative clinical imaging of demyelination and remyelination in ischemic stroke

Myelin is a major structural component of the brain playing a vital role for its proper function. Demyelination is
commonly observed in numerous neurological conditions where it can be either a primary pathological substrate
or a direct consequence of damage to axons, neurons, or oligodendroglia caused by various injuries. Recent
animal studies indicate that demyelination is an important component of the sequence of pathological events in
ischemic stroke. After initial myelin damage, infarcted brain tissue undergoes either progressive demyelination
and necrosis or remyelination accompanied by axonal remodeling. Current knowledge about myelin damage
and repair in stroke is exclusively based on animal models. We propose a clinical study that aims to a)
demonstrate the feasibility of quantifying myelin loss and recovery in stroke patients; b) establish a relationship
of demyelination and remyelination with various clinical factors; and c) identify associations of demyelination and
subsequent remyelination with functional recovery after stroke. The study is driven by the overarching hypothesis
that demyelination in stroke provides an indicator of the extent of overall tissue injury, and, vice versa, brain
tissue repair after stroke can be monitored by quantifying remyelination. Demyelination and remyelination in
stroke can be assessed with high specificity and sensitivity using a novel quantitative magnetic resonance
imaging (MRI) technique named single-point macromolecular proton fraction (MPF) mapping. This method has
been extensively validated by histology in animal models and demonstrated promising results in human studies
of neurological diseases and brain development. As a clinically-targeted quantitative myelin imaging modality,
MPF mapping offers a number of advantages including fast acquisition, independence of magnetic field strength,
insensitivity to changes in magnetic relaxation caused by iron deposition, high reproducibility, and straightforward
implementation in a clinical setting. In the proposed study, we will further improve the MPF mapping method by
accelerating acquisition and introducing a novel reconstruction algorithm that computes absolute
macromolecular proton concentration (MPC) to eliminate the confounding effect of edema on MPF. Whole-brain
MPF mapping protocols with less than 3 minutes total scan time will be implemented for the most widely used
clinical MRI platforms based on unmodified manufactures’ pulse sequences. We will prospectively recruit acute
and sub-acute ischemic stroke patients during inpatient treatment and conduct follow-up examinations for six
months. Based on longitudinal quantitative myelin assessment using MPF/MPC and a series of clinical outcome
measures in several functional domains, the following hypotheses will be tested: 1) MPF/MPC is capable of
detecting remyelination during post-stroke brain tissue recovery; 2) an extent of demyelination at baseline and/or
subsequent remyelination observed longitudinally is associated with outcomes of rehabilitation; and 3) inclusion
of quantitative myelin measures into predictive statistical models improves prognosis of post-stroke rehabilitation.

Public health relevance
Myelin is a major structural component of brain tissue, which is severely damaged in stroke along with neural cells. The project aims to non-invasively investigate an extent and dynamics of myelin injury and subsequent repair in ischemic stroke using MRI and identify relationships between myelin content changes and post-stroke rehabilitation outcomes. The assessment of demyelination and remyelination in stroke could be used to guide patient care and improve selection of patients for clinical trials investigating new therapies and rehabilitation techniques.